Safety and modulation of ABCC9 pathways by nicorandil for the treatment of hippocampal sclerosis of aging (SMArTâHS)

Abstract
The proposed project is a pilot clinical trial investigating a potential treatment for hippocampal
sclerosis of aging (HS-Aging). A major subtype of “Alzheimer's disease and related dementia” (ADRD),
HS-Aging affects 10-25% of all elderly individuals. HS-Aging is typically misdiagnosed as Probable AD
or AD-type dementia in the clinical setting. Unfortunately, there currently is no validated biomarker to
diagnose HS-Aging during life, and there is no known therapy.
We will test the safety and efficacy of nicorandil for HS-Aging, based on our prior work elucidating
a pharmacologically targetable mechanism underlying the disease. Nicorandil is a vasorelaxant drug,
used clinically to treat chronic heart failure in the elderly population. Pharmacologically, Nicorandil is
an agonist for a protein (SUR2) that is encoded by a gene that we found to be linked to HS-Aging risk.
Primary specific aims follow:
Specific Aim #1: Evaluate safety and neurodegenerative biomarkers linked to HS-Aging
pathology in nicorandil vs. placebo treated subjects by:
a. Conducting a double-blind, randomized, placebo-controlled, clinical trial of nicorandil in 62
participants (both sexes, >75 years old, CDR 0.5 or 1, with HS-Aging profile in CSF and MRI
biomarkers [amyloid and phospho-tau negative, with evidence for hippocampal atrophy; A-/T-/N+])
over a 96-week treatment period; b. Evaluating the safety of nicorandil administration in the elderly at
risk for HS-aging (this is the primary outcome measure) that will inform future trial design; and, c.
Measuring structural MRI (3D-T1; hippocampal atrophy is the main efficacy outcome measure),
cognitive tests, and CSF levels of nicorandil, tau, phospho-tau, and Aβ(1-42) at baseline and week 96.
Specific Aim #2: Optimize and further explore HS-Aging biomarkers by:
a. Refining MR imaging analysis (including hippocampal volumetric assays, arterial spin labeling
(ASL), diffusion tensor imaging (DTI), magnetic resonance spectroscopy (MRS) techniques that may
distinguish participants with probable HS-Aging from those with positive AD biomarkers; b. Performing
proteomic discovery analysis in CSF to identify and evaluate potential HS-Aging biomarkers to
complement the A/T/N framework utilizing our prospective cohort with Aβ(1-42), phospho-tau, and
neurodegeneration markers and MR imaging as a control cohort for AD. This specific aim will directly
test and enhance the clinical utility of the A/T/N framework for diagnosis of degenerative disease state;
and, c. Following our published and replicated neurocognitive testing marker that is associated with
HS-Aging pathology, we will optimize the clinical and neurocognitive criteria for disease diagnosis
based on the prospects of a relatively long-running (96 week) early-phase clinical trial.

Public health relevance
Narrative This proposal seeks (through “drug repurposing”) a novel drug therapy as a potential treatment for hippocampal sclerosis dementia. There is no current treatment for this disease that affects approximately 1/4th of the elderly but which is seldom recognized clinically because it mimics Alzheimer's disease. As such, the proposed study represents a cutting-edge, data-driven, low-cost, exploration of a novel disease relevant pathway that may hold promise for our global efforts targeting late life dementia.